Administrative Core

Core A (Administrative Core) will facilitate scientific interactions, coordination and integration between the three Projects and three scientific Cores, to maximize the success of this Program Project. This includes maintaining communication among the investigators in all components of the Program, leading the decisionmaking process, continuous monitoring of the overall progress of the Program, and providing overall grant management and coordination with the Sponsor. The Administrative Core will be responsible for administering both the External and Internal Advisory Committees and facilitating the interactions of these Boards with the research team. Core A will provide the administrative infrastructure for the three Research Projects and all Cores, including fiscal management, clerical support, manuscript preparation, meeting organization, shared data management and trafficking, quality control, and planning. Core A will also maintain records relevant to human embryonic stem cell research (ESCRO approvals and MTAs) to insure appropriate use of these cells. The Core will allocate funds for each Project and each Core facility. Monthly, quarterly, and annual financial reports, and projections, will be prepared by Core A. Core A will be used equally by all project leaders and core directors. These administrative, accounting, planning and quality control services are essential for the success and smooth operation of the Program Project.